Understanding and regulating skeletal muscle progenitor and stem cell states through metabolic and epigenetic modulation

Project Summary
Skeletal muscle is one of the most regenerative tissues in the human body. Skeletal muscle progenitor cells
(SMPCs) contribute to developmental myogenesis, and skeletal muscle stem cells (satellite cells, SCs)
contribute to postnatal muscle homeostasis and regeneration. In Duchenne Muscular Dystrophy (DMD), a
prevalent but fatal X-linked muscle wasting disease that affects 1:5000 live male births, a loss-of-function
mutation in the DMD gene results in the absence of functional dystrophin protein to stabilize muscle fibers. This
leads to continuous damage from repeated muscle degeneration and regeneration and compromises the
regenerative ability of SCs. There is currently no cure for DMD. Differentiating human pluripotent stem cells
(hPSCs) into SCs is a valuable resource for developing cell replacement therapies for DMD. However, current
hPSC directed myogenic differentiation protocols result in embryonic/fetal-like SMPCs that cannot be maintained
over multiple passages (i.e. self-renew) in culture. SMPCs also do not engraft as efficiently as postnatal SCs,
and it is not known how to mature SMPCs to SCs because it is unclear how they molecularly differ. Metabolism
plays a key role in regulating cell state and function in stem cells across development. We performed single cell
RNA sequencing analysis that demonstrated that expression of most genes in glycolysis, tricarboxylic cycle, and
oxidative phosphorylation decrease across human myogenic development. However, how metabolic activity
supports SMPCs or can be used to transition SMPCs to SCs in humans has not been investigated beyond the
transcriptional level. By more closely evaluating the metabolic profiles of tissue-derived SCs and hPSC-derived
myogenic subpopulations including hPSC-derived SMPCs (hPSC-SMPCs), specific metabolic enzymes and
metabolites in the aforementioned pathways will be targeted as candidates to support hPSC-SMPC self-renewal
or promote hPSC-SMPC maturation to SCs in culture. Tightly connected to metabolism is the epigenome which
has a direct role in transitioning between cell states, particularly through modulating chromatin accessibility at
cis-regulatory regions to mediate transcription factor (TF) binding and control gene expression. Evaluating
differences in chromatin accessibility of TF binding motifs between the same myogenic populations identifies
TFs that support and regulate SMPC and SC states. Several TF candidates have been identified as potential
regulators of SMPC-to-SC maturation. Expression of TF candidates will be modulated to support hPSC-SMPCs
or promote their maturation toward SC fate. This work will for the first time shed light on the metabolic and
epigenetic roles in maintaining and transitioning between human muscle progenitor and stem cell states. These
findings will enhance the regenerative potential of hPSC-derived muscle cells and enable the development of
improved myogenic cell therapies for DMD. This study will be performed at the University of California, Los
Angeles under the mentorship of Dr. April Pyle, an expert in hPSC and skeletal muscle biology, in my endeavor
to becoming a research scientist in the field of regenerative medicine.

Public health relevance
Project Narrative A promising therapy for Duchenne Muscular Dystrophy patients is transplantation of healthy satellite cells (SCs) derived from human pluripotent stem cells (hPSCs) to restore skeletal muscle function. However, current hPSC myogenic differentiation protocols result in embryonic- or fetal-like skeletal muscle progenitor cells (SMPCs) that cannot be maintained in culture and are less regenerative than adult SCs. By evaluating differences in metabolism and chromatin accessibility between hPSC-SMPCs and SCs, I propose to identify targets that manipulate metabolic and gene regulation processes to promote hPSC-SMPC self-renewal or maturation to an SC-like state.